Assessing pathogen persistence and the host response to Treponema pallidum in a newly developed mouse model of congenital syphilis

Syphilis is a sexually transmitted, multistage systemic infectious disease with ~6-12M new infections reported
globally each year. Treponema pallidum subspecies pallidum (Tp) mother-to-child transmission results in
adverse pregnancy outcomes including miscarriage, stillbirth, and congenital syphilis (CS) in newborns. If
infected infants do not receive adequate treatment, infection can result in developmental defects, skeletal
abnormalities and even development of blindness, deafness etc. CDC has described a substantial increase in
CS cases over the years with 3,755 reported in 2022, which showed >11-fold increase just within one decade.
The major goal of this project is to establish a mouse model of CS, determine changes in host immune
responses, and lay foundation for diagnostics and vaccine development in the future.
C4-deficient (C4-D) guinea pigs were previously used to study CS by Dr. Wicher; however, the model
has not been adopted by any other laboratory in the last three decades. Under our ‘International Collaboration
on an Infectious Diseases Research (ICIDR) project, U01-AI115497 with Dr. Giacani at University of Washington
and the late Dr. Arturo Centurion-Lara at Cayetano Heredia University in Peru, we described the function of two
outer membrane associated lipoproteins and identified Tp0954 as the first placental cell binding adhesin. We
also tested vaccine candidates against syphilis in the rabbit infection model in that project. Rabbits have been
used to propagate Tp, and determine vaccines efficacy against syphilis; however, not for assessing CS.
Furthermore, rabbits cannot be examined by the existing In Vivo Imaging System (IVIS) to determine colonization
at different stages of infection by live imaging. Finally, not many immunological reagents are available to study
innate and adaptive immune responses against Tp in the rabbit model.
Our collaborator, Dr. Giacani has generated a GFP-expressing infectious SS14 strain of Tp that he
generously provided to us to generate preliminary data for this proposal. Using this Tp strain and Balb/c mice,
we could detect Tp colonization of different organs in both parents and pups by live imaging using IVIS-200. The
results were confirmed by recovery of live, motile spirochetes from organs into medium. We hypothesize that
mouse model could be used to study sexual and vertical transmission of Tp, examine by live imaging at different
stages and assess inflammatory responses, and induction of protective humoral immunity that could prevent
vertical transmission to the later generations of pups. The following aims will test our hypothesis. (1). Determine
whether infection of Balb/c mice with Tp triggers immune responses to facilitate vertical and potentially horizontal
transmission of this spirochete. (2). Determine whether specific humoral immunity generated during Tp infection
prevents/reduces mother-to-pups transmission in the later generations. The major significance of this study is
to establish a mouse model for CS, determine host immune responses, conduct longitudinal studies to identify
vaccine candidates against syphilis/CS to be tested in the future.

Public health relevance
Mother-to-child transmission of syphilis causing Treponema pallidum results in adverse pregnancy outcomes including miscarriage, stillbirth, and congenital syphilis (CS) in newborns. Despite substantial increase in CS cases to 3,755 in the United States in 2022, studies of CS have lagged due to unavailability of a suitable animal model. Our promising data using mice and green light emitting bacteria detected by live imaging showed T. pallidum transmission to pups and thus, offers us a unique and novel animal model to study CS.